Advancing Non-Invasive Diagnostics and Treatments of Deployment-Related Chronic Lung Disease in Gulf War Veterans

Rationale. An increased incidence of respiratory complaints has been identified in Veterans of the Gulf War
(GW) [and post-9/11 conflicts. An inhalational injury is suspected given numerous potential exposures to airway
toxins. A landmark study (1) in 2011 described a cohort of post-9/11 soldiers with unexplained dyspnea and
impaired exercise tolerance that underwent surgical lung biopsy; findings showed evidence of chronic
inflammation surrounding thickened fibrotic bronchioles referred to as deployment related chronic bronchiolitis
(DR-CB) in this proposal. We performed a preliminary analysis of chest CT scans previously obtained on a
subset of these soldiers using parametric response mapping (PRM), a recently-developed CT analytic technique
that measures differential lung density between inspiratory and expiratory scans. Here we provide the first
evidence linking the histopathologic features of DR-CB with an abnormal radiographic signature indicative of
functional small airways disease (fSAD). We show that forced oscillation technique (FOT), a pulmonary function
test, may also non-invasively identify small airways disease in deployed Veterans. We provide additional data
demonstrating that key histopathologic features of DR-CB are recapitulated in a transgenic murine model of
inducible, specific, and sustained injury to progenitor club cells located within the airway epithelium. This finding
and additional associational evidence indicate that numerous airway toxins present during deployment mediate
their deleterious effects via a club cell injury pathway. We further implicate an increase in apoptotic club cells
and profibrotic macrophage accumulation in the pathogenesis of chronic bronchiolitis. Our collective data and
proposed studies address an urgent need to better understand, diagnose, and treat DR-CB.]
Hypothesis: [We hypothesize that the histopathologic features of DR-CB in Veterans are manifested as
increased functional small airways disease detectable by PRM and FOT. We further hypothesize that the
histopathologic features of chronic bronchiolitis induced by club cell injury in mice result from increased apoptotic
cell burden which triggers accumulation and profibrotic activation of lung macrophages.]
Aim 1: To determine whether PRM identifies an increase in fSAD as a radiographic surrogate [for the
histopathologic abnormalities that define] DR-CB. In this Aim, we will obtain comprehensive data sets (including
high resolution CT scans) on cohorts of GW and Post-9/11 Veterans that underwent clinically-indicated
evaluations for unexplained dyspnea at the Vanderbilt University Medical Center and the New Jersey War
Related Illness and Injury Study Center. We will first quantify PRM classifications in Veterans with
histopathologic evidence of DR-CB and identify a predictive threshold of PRMfSAD that may aid in the diagnosis
of this condition (Aim 1a). We will then use this threshold to compare cohorts of non-biopsied Gulf War and
Post-9/11 Veterans for radiographic evidence of DR-CB (Aim 1b) and assess relationships between PRMfSAD
and FOT (Aim 1c).]
Aim 2: To determine whether [histopathologic features of murine chronic bronchiolitis caused by sustained club
cell injury can be prevented and (or) ameliorated by disrupting profibrotic macrophage responses to apoptotic
cells. Using our murine model, we will first identify relationships between club cell injury, apoptotic cell burden,
oxidative stress, and lung macrophage phenotype (Aim 2a) and thereafter determine whether CD36 blockade
(Aim 2b) or azithromycin (Aim 2c) can prevent and (or) resolve chronic bronchiolitis in mice.]
Benefit to Veterans: [The application of PRM and FOT technology will significantly improve our ability to safely
diagnose DR-CB and thus advance assessment of its prevalence amongst deployed Veterans, including those
with Gulf War Veterans Illness. Our focused investigation on club cell injury will enhance our understanding of
DR-CB pathogenesis in response to numerous respiratory hazards and expedite the development of
preventative or active treatments for this debilitating condition.]

Public health relevance
An increase in unexplained persistent respiratory complaints in Gulf War [and Post-9/11 Veterans] has led to mounting concerns that region or conflict specific inhalational hazards cause occult lung injury resulting in chronic small airways inflammation and fibrosis, referred to as deployment-related chronic bronchiolitis (DR-CB) in this proposal. [At present, DR-CB is difficult to diagnose without resorting to surgical lung biopsy. This study will determine whether parametric response mapping, a new CT scan analytical technique, can substantially advance our ability to non-invasively diagnose DR-CB and assess its prevalence in symptomatic SW Asia- deployed Veterans, including those with Gulf War Veterans Illness. The pathogenesis of DR-CB is poorly understood and no treatments for this disorder have been tested in humans or animal models. This proposal utilizes a novel murine model of chronic bronchiolitis to elucidate critical pathologic pathways and potential treatments for this disorder.]